Acing the Plastic Problem with an Automated Cell Culture Cleaning Device (AC3D)

The scope of this effort will be focused on activities that have the potential to provide proof-of-concept for the proposed AC3D approach.